Informatics, Coordination and Service Center for the Mutant Mouse Resource and Research Centers

PROJECT SUMMARY – OVERALL
The Mutant Mouse Resource and Research Centers (MMRRC) is the NIH’s premier repository for the
cryopreservation and distribution of genetically engineered and spontaneously mutated mouse alleles held as
live mice, germplasm, and embryonic stem and other cell lines. The MMRRC’s four breeding and distribution
facilities at UC Davis (CA), UNC Chapel Hill (NC), UM Columbia (MO), and The Jackson Laboratories (ME) are
centrally organized through the Informatics, Coordination and Service Center (ICSC), which maintains the
MMRRC’s web presence and provides customer service to the biomedical research community. As such, the
ICSC is responsible for all MMRRC order processing, the coordination of strain donations, data curation, metrics,
and the consortium’s public education & outreach campaign. The objective of this particular application is the
continued operation of the ICSC at the UC Davis campus. This will be accomplished with three designated Cores
that cater to MMRRC (1) Coordination, (2) Customer Service & Public Relations, and (3) Informatics. Each Core’s
Project Lead will direct activities designed to expand the MMRRC’s operations and excellence. More specifically,
the Coordination Core will facilitate internal as well as external MMRRC interactions and collaborations, manage
technical staff, organize MMRRC exchanges with the ORIP/DPCPSI/OD/NIH Program Official, and coordinate
progress reports as well as site visits. The Customer Service & Public Relation Core will act as the first point of
contact for donation, data, and order inquiries from the research community, using web-based interaction as well
as face-to-face representation at professional conferences in addition to targeted efforts to raise awareness of
the MMRRC as a valuable research resource. The Informatics Core will be responsible for the development,
implementation, expansion, and maintenance of the MMRRC website, the relational databases associated with
all ICSC services, communication services hosted at the ICSC, metrics reporting, and the analytical marketing
effort. The ICSC will furthermore engage an Applied Research Project examining the impact of the MMRRC on
the research community at large, using supervised literature analyses. Under its current leadership, the ICSC-
coordinated MMRRC consortium has increased its user base by >50%, nearly doubled its holdings, and orders
reached an all-time high in 2019. This was accomplished by streamlining donation and order processing and
through targeted social media and email campaigns with innovative, user-centered information technology. The
ICSC operation at UC Davis is, hence, well suited for this funding opportunity’s purpose, namely to promote the
MMRRC as the NIH go-to resource to ensure the highest standards of experimental design and quality control
to optimize the reproducibility of mutant mouse research. This is significant because it caters directly to the NIH
mission of promoting research to generate robust and reproducible results for the advancement of human health.

Public health relevance
PROJECT NARRATIVE Mouse models are a cornerstone of basic research and the development of therapeutic interventions. The NIH Mutant Mouse Resource & Research Centers (MMRRC) are a group of four repositories (University of California, University of Missouri, University of North Carolina, and The Jackson Laboratories) that collectively curate and distribute mouse strains. The Informatics, Coordination and Service Center (ICSC) funded under this opportunity provides organizational leadership, quality management, and informatics services for the MMRRC to enable cryopreservation, cataloging, and distribution of almost 60,000 mouse strains, embryonic stem cell lines, plasmid vectors, and antibody-producing hybridoma to the research community for the advancement of human health.